Deciphering the Critical Determinants of Enteric and Tumor Niche Colonization by Microbes in Colorectal Cancer

PROJECT SUMMARY/ABSTRACT: The proposed study seeks to use the established association of
Fusobacterium nucleatum (Fn) with colorectal cancer (CRC) as a model to decipher critical determinants of
microbial tumor niche colonization and examine mechanisms by which microbes contribute to CRC. Within the
CRC tumor microenvironment (TME), malignant cells are surrounded by a complex range of non-transformed
cells and a diverse collection of tumor-infiltrating microorganisms. Fusobacterium nucleatum (Fn), a member of
the human oral microbiota, is found enriched in colorectal cancer (CRC) compared to non-cancer colon tissue,
across patient cohorts worldwide. Previous work by our group and others has demonstrated that patients with
CRC tumors harboring high levels of Fn have poorer survival, that Fn persists in metastatic disease, and that
microbiome modulation targeting Fn could change the course of this disease. Additionally, our recent work has
demonstrated that Fusobacterium exists within regions of oral and CRC tumors that are poorly vascularized and
highly immunosuppressive; characterized by myeloid cell infiltration, upregulation of immune checkpoint proteins
PD1, CTLA4 and Lag3, reduced T-cell infiltration - the same regions that are recalcitrant to immunotherapies
and chemotherapeutics, thus supportive of cancer progression.
However, mechanistic insights into how this microbe is homing to and colonizing the TME and how it is
contributing to disease initiation or progression are severely lacking, which impedes prophylactic and therapeutic
progress against Fn in cancer. Here, in preliminary studies, we isolated and characterized the genomes and
epigenomes of >150 Fn strains from CRC tumors and the oral cavity and discovered that within Fn subspecies
animalis, there are two distinct clades that differ in their enrichment in CRC, which we named Fna oral-clade and
Fna CRC-clade. We show that Fna CRC-clade is the only Fn group significantly enriched in human tumors and
fecal specimens. Pangenomic investigations of Fna clades revealed genetic factors whose putative functions
are canonically associated with pathogenic colonization of the human gastrointestinal (GI) tract. These included
operons for the metabolic utilization of the gastric substrates ethanolamine (EA) and 1,2-propanediol (1,2-PD),
and a glutamate decarboxylase acid resistance (AR2) system (associated with extreme acid resistance) of
relevance to survival during GI transit and immune-modulation in the TME. This proposal’s objective is to
interrogate these genetic factors, enriched in Fna CRC-clade but absent in oral-clade, as critical determinants of
gastrointestinal transit, colonization, and survival within CRC tumors. Our team brings together expertise in
synthetic microbiology, pangenomics, and genetic engineering (PI Johnston), preclinical cancer models, and
tumor-infiltrating microbiota (PI Bullman), in addition to metabolomics (Co-I Raftery). Thus, we are poised to
provide mechanistic insights on the genetic basis of Fna’s pathoadaptation to CRC and could identify new
therapeutic targets against this tumor-infiltrating microbe found enriched in CRC-patient cohorts worldwide.

Public health relevance
PROJECT NARRATIVE: Fusobacterium nucleatum (Fn) is enriched in colorectal cancer (CRC) tissue compared to normal tissue, where it dominates the tumor-infiltrating microbiota and colonizing distinct tumoral microniches; however, the underlying factors that facilitate Fn’s selective colonization and persistence in CRC remain largely unknown. Through genomic analysis of oral and CRC Fn strains we have identified a CRC-enriched Fn subgroup with distinguishing genetic features, and here we propose to interrogate the role of these features in gastrointestinal and tumor- niche colonization. If successful, this work will provide mechanistic insights on the genetic basis of Fn’s tumor colonizing capabilities and guide prophylactic and therapeutic interventions against Fn – a potential ‘oncomicrobe’ that has been found enriched in CRC patient cohorts worldwide.